Biological Imaging Module

Biological Imaging Module. Located at the 4th and 7th floors of the MVRC provides services and consultation for preparing and analyzing the structure of biological specimens in two main areas: i) Analytical Imaging ?Managed by Gabriel Gaidosh, ii) Histology ?with the technical assistance of Magda Celdran, The Module is directed by Valery Shestopalov, PhD and co-directed by Victor Perez, M.D. Technical and administrative details are in the specific sections and also mentioned in the BPEI web site http://bascompalmer.org/research-cores/histologv